Role of social touch and social memory in organizing naked mole-rat colonies

Project Summary/Abstract
The East African naked mole-rat is arguably the most social animal in the mammalian
kingdom, maintaining decades long harmonious communal living with upwards of hundreds of
colony members. Most mammals, including humans, are highly social and cooperation during
social interactions is a critical component of our daily lives. Unfortunately, in many diseases of
the nervous system, including autism, schizophrenia, and chronic depression, sociability is greatly
diminished, and the mechanisms as to why remain poorly defined. Understanding neuronal
mechanisms that facilitate social engagement in a highly social animal, the naked mole-rat, could
provide valuable new insights to this problem, that can complement work being done in more
traditional model organisms.
We hypothesize that touch is an essential sensation in naked mole-rats that allows the
animals to navigate complex social interactions such as recognizing and keeping memories of
large numbers of colony members. We have keyed in on touch because these animals are blind,
most other senses are diminished, and they have evolved an exquisitely sensitive tactile system
from the periphery to the sensory cortex. In our preliminary studies that serve as rationale for this
proposal and support our hypothesis, we find that naked mole-rats engage in an active form of
face-to-face interaction tens of thousands of times per day, and the area of their hippocampus
dedicated to social memory appears greatly expanded. Thus, we are envisioning a model
whereby touch is used to create maps of individuals in their world, sending powerful inputs to an
expanded hippocampal network, allowing the animals to quickly identify and remember other
animals to perform communal tasks in harmony.
This is a completely new direction for my lab, working in a non-traditional model organism
and studying neural circuits that are new to us. However, we strongly believe the upside of this
work is high, and since these animals are mammals, we will find generalizable principles that can
increase our fundamental understanding of key neural mechanisms for social recognition, social
memory, and pro-social behaviors more broadly. Indeed, neuroscience is filled with examples of
uncovering general principles from studying animals with extreme adaptations that make them
ideally suited for the problem at study. We have developed tools and approaches to perform
modern neuroscience experiments in naked mole-rats and firmly believe the time is ripe to tackle
this fundamental problem within the social neuroscience field.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will provide a molecular, neuronal, and behavioral dissection of how social touch is used for encoding the memory and identities of large numbers of conspecifics. It remains unclear how the human brain can achieve this difficult task, and therefore, studies in a specialist animal like the naked mole-rat could provide critical new insights. The project is relevant to the mission of NIH because of its potential to enhance our fundamental understanding of the role of touch in shaping social interactions, which is critical for our well-being and oftentimes disrupted in neurological and psychiatric diseases.